Genetic Predisposition to Chronic Lymphocytic Leukemia (CLL)

Project Summary
CLL is the most common leukemia of adults in North America, with about 20,000 new cases per year,
and remains incurable. Although a small subset of patients has indolent disease, in the majority of cases CLL
is characterized by steady progression toward therapy and once treated, patients are likely to die of the disease
or its complications. The primary known risk factor is a family history of the disease, and CLL is one of the most
heritable of all cancers, yet the genetic basis of this heritability remains largely unknown. Neither family-based
linkage studies nor genomewide association studies (GWAS) have identified clinically useful genetic variants.
In our prior work, we hypothesized that the high heritability of CLL may lie in rare germline variants associated
with intermediate disease risks, and we identified ATM as the first risk gene for CLL. We further demonstrated
that rare germline missense variants in ATM are associated with loss or mutation of the other allele in the tumor,
as expected for a cancer predisposition gene. We have since identified these germline ATM variants in 25% of
our CLL clinic population, suggesting that ATM may be an important germline driver of CLL. In this grant we will
prospectively enroll CLL subjects who have been evaluated for germline ATM variants into a registry that will
allow us to determine the association of ATM germline variants with CLL clinical features, development of other
cancers and family history of cancer. We will also perform functional assessment of the ATM protein, to
determine the impact of the most common and highest risk of these alleles on protein function. Additionally, we
will expand the prior analysis that identified ATM, to include all publicly available CLL sequencing data, and
employ both a novel highly sensitive variant calling method developed by Google and a novel ancestry matching
method. Our preliminary data with this larger cohort and improved methodology have so far confirmed our ATM
finding and identified FANCE and CHEK2 as additional CLL risk genes, suggesting a role for other DNA repair
genes in CLL susceptibility. We will also focus on higher risk familial CLL with additional exome sequencing,
with a similar analysis as above, and with epigenomic profiling with ATAC-seq to explore the non-coding genome.
Using a unique cohort of highly impacted families, we will combine ATAC-seq with whole genome and RNA
sequencing, to both characterize the gene targets of the GWAS alleles previously identified in CLL, and identify
novel noncoding risk variants that impact transcription regulation. This project is feasible because of the rich
resources of our unique, well-annotated tissue banks of familial CLL developed over the last 15 years. Our goal
with this work is not only to enhance our understanding of the genetic basis of CLL, but also to provide the basis
for improved screening and counseling of CLL patients in the clinic, through eventual initiation of clinical trials to
assess the utility of genetic testing in this patient population.

Public health relevance
Project Narrative CLL is the most common leukemia of adults, yet incurable. The most significant risk factor for CLL is a family history of the disease, and we have identified mutations in the ATM gene as associated with CLL. In this work we will further characterize the clinical and biological effects of these mutations, as well as identify other genes associated with CLL risk, with the goal of providing counseling and screening to patients and families.